A Functional Analysis of Arginine Methylation

PROJECT SUMMARY/ABSTRACT
Our goal is to broadly understand the biological roles of arginine methylation, a very common post-translational
modification (PTM). This PTM is deposited by at least nine protein arginine methyltransferases (PRMTs) in
mammals. Like lysine methylation, arginine methylation of a substrate often recruits an effector molecule to the
newly created methyl-motifs. Unlike lysine methylation, relatively few effects have been identified for
methylarginine marks. This paucity of identified methylarginine (Rme) mark effectors and the signaling roles of
the known effectors define a knowledge gap that will be addressed here. By performing proteomic screens, we
have identified a novel reader for Rme marks, called SART3. This effector does not harbor a Tudor domain
which is usually found in “traditional” readers of Rme marks, but rather it carries a series of HAT (Half-a-TPR)
repeats that are rich in aromatic amino acids. Here, we plan to characterize this interaction and investigate the
possibility that other TPR repeat-containing proteins may be involved in sensing arginine methylation. Also, we
are investigating the functions of two known effects of Rme marks, called SND1 and TDRD3. Through a
combination of mouse work and protein array studies, we have determined that SND1 can likely directly activate
the kinase activity of S6K2, and that TDRD3 can play a role in the DNA damage response.

Public health relevance
PROJECT NARRATIVE We propose to investigate the mechanisms by which methylarginine marks function as docking sites for effector proteins by identifying new effectors and characterizing known effectors in-depth, to better understand the signal transduction pathways that are regulated by arginine methylation.